Blood Pressure in Advanced Chronic Kidney Disease

DESCRIPTION (provided by applicant): This is an application for a K23 award for Dr. Nisha Bansal, a nephrologist at the University of California, San Francisco. Dr. Bansal is establishing herself as a young investigator in clinical research of cardiovascular disease and hypertension in chronic kidney disease. This K23 award will provide Dr. Bansal with the support necessary to accomplish the following goals: (1) to investigate the impact of blood pressure in patients during the transition between chronic kidney disease and end-stage renal disease; (2) to implement advanced biostatistical methods in clinical studies; (3) to work with a large multi-center cohort study; and (4) to develop an independent clinical research career. To achieve these goals, Dr. Bansal has assembled a mentoring team comprised of a primary mentor, Dr. Chi-yuan Hsu, Division Chief in Nephrology at UCSF, who conducts clinical research on the epidemiology and complications of chronic kidney disease, and three co-mentors and one scientific advisor: Dr. Alan Go, an expert on cardiovascular disease health services research and clinical epidemiology in chronic kidney disease; Dr. Elyse Foster, Director of the UCSF Adult Echocardiography Laboratory; Dr. Charles McCulloch, an authority in the use of statistical methods for longitudinal data analysis; and Dr. Raymond Townsend, who has expertise in hypertension and pulse wave analysis in chronic kidney disease. Cardiovascular disease is the leading cause of mortality in chronic kidney disease. Dr. Bansal's research will study the impact of blood pressure on cardiovascular disease and mortality during the transition between chronic kidney disease and end-stage renal disease (Aim 1); the association between central aortic pressures and outcomes during this transition period (Aim 2); the association between aldosterone, blood pressure and outcomes during the transition between chronic kidney disease and end-stage renal disease (Aim 3); and the impact of the use of anti-hypertension medications on outcomes during this transition period (Aim 4). To achieve these aims, Dr. Bansal will utilize a unique group of patients with chronic kidney disease assembled as part of the NIDDK-funded Chronic Renal Insufficiency Cohort (CRIC), a national study composed of 7 clinical centers. She will utilize advanced multivariate statistical analyses to accomplish these aims. This research will form the basis for a cohort study to investigate the impact of blood pressure in patients with heart failure and advanced chronic kidney disease, to be proposed in an R01 grant application before the end of the K award.

Public health relevance
PUBLIC HEALTH RELEVANCE: Improved understanding of the impact of blood pressure, measurement of blood pressure, and determinants of blood pressure in patients with advanced stages of kidney disease is critical to improve long-term cardiovascular complications and survival in this high-risk group of patients. NARRATIVE Improved understanding of the impact of blood pressure, measurement of blood pressure, and determinants of blood pressure in patients with advanced stages of kidney disease is critical to improve long-term cardiovascular complications and survival in this high-risk group of patients. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Cardiovascular disease is the leading cause of mortality in patients with chronic kidney disease (CKD) and end-stage renal disease (ESRD). Hypertension is a strong and treatable risk factor for cardiovascular disease and is very common in patients with kidney disease. However, the relation between blood pressure and outcomes remains complicated in patients with kidney disease. Previous studies have found that while higher blood pressure predicts worse survival in CKD patients, lower blood pressure predicts worse survival in ESRD patients. These discrepant findings may be explained in part by limited knowledge of central blood pressures and a high prevalence of systolic dysfunction in patients with kidney disease. An important and poorly understood time in the chronology of kidney disease is the transition from CKD to ESRD. Hypertension is extremely prevalent during these advanced stages of CKD, despite treatment. Our knowledge of the impact of elevated blood pressure during this period from advanced CKD through incident CKD remains elusive given the paradoxical relationships between blood pressure and outcomes seen in CKD and ESRD. Knowledge about the role of central blood pressures in CKD patients is also limited. A better understanding of blood pressure during this transition could inform therapeutic choices to improve mortality. Alterations of the renin-angiotensin-aldosterone system (RAAS) contribute to elevated blood pressure in advanced stages of kidney disease. Elevated aldosterone may play a significant role in blood pressure severity and adverse outcomes in advanced stages of CKD. Despite inhibition with anti-RAAS medications, aldosterone may not be completely blocked. Furthering our knowledge of aldosterone and anti-hypertensive medications on blood pressure and outcomes during the critical window between CKD and ESRD would enable us to tailor interventions in an area uninformed by randomized controlled trials. To fill this gap in scientific knowledge, we propose to study a unique group of patients with CKD assembled as part of the NIDDK-funded Chronic Renal Insufficiency Cohort (CRIC). We propose the following 3 specific aims: Aim 1: To determine the association between brachial artery blood pressure level with cardiovascular disease and mortality during the transition between chronic kidney disease and end-stage renal disease (defined as advanced chronic kidney disease and incident end-stage renal disease). Hypothesis 1a: In advanced chronic kidney disease, higher blood pressure level is associated with a greater risk of cardiovascular events and mortality. In those who progress to end-stage renal disease, higher blood pressure level is associated with a greater risk of cardiovascular events, mortality, and changes in left ventricular structure after onset of end-stage renal disease. Hypothesis 1b: The association between higher blood pressure level and cardiovascular events and mortality will be strengthened in those with normal systolic function and weaker in those with decreased systolic function. Aim 2: To determine the association between central aortic pressures with cardiovascular disease and mortality during the transition between chronic kidney disease and end-stage renal disease. Hypothesis 2: Independent of brachial artery blood pressure, central aortic pressures as measured by pulse wave analysis, and aortic stiffness as measured by carotid-femoral pulse wave velocity, will be strong independent predictors of cardiovascular disease and mortality in patients with advanced chronic kidney disease and end-stage renal disease. Aim 3: To determine the association between aldosterone, blood pressure, cardiovascular disease, and mortality during the transition between chronic kidney disease and end-stage renal disease. Hypothesis 3: Elevated serum and urine aldosterone levels will be associated with higher blood pressure levels, greater risk of cardiovascular events, changes in left ventricular structure and mortality in advanced chronic kidney disease and incident end-stage renal disease. Aim 4: To determine how the use of blood pressure reduction medications- in particular, inhibitors of the renin-angiotensin-aldosterone system - impacts aldosterone levels, cardiovascular disease and mortality during the transition between chronic kidney disease and end-stage renal disease. Hypothesis 4: Use of angiotensin converting enzyme inhibitors and angiotensin receptor blockers will be associated with partially attenuated aldosterone levels, lower blood pressure, fewer cardiovascular events, less change in left ventricular structure, and decreased mortality in patients with advanced kidney disease and incident end-stage renal disease.